Mechanisms underlying interferon-induced T peripheral helper cell differentiation

PROJECT SUMMARY
Systemic lupus erythematosus (SLE) is a highly morbid autoimmune disease. Despite recent advances, there is
a critical unmet need to discover novel therapies that precisely target the pathophysiological basis of this disease.
Emerging data suggest the importance of a relatively recently discovered cell type, the T peripheral helper (Tph)
cell. It is pathologically expanded in lupus patients, highly correlated with disease activity, and produces factors
that support autoantibody production. Our preliminary data suggest that one of the reasons why these cells are
expanded in these patients is the high levels of circulating type I interferon, a cytokine. In this proposal, we will
apply cutting-edge biochemical, epigenetic, and genetic approaches to human T cells (both healthy controls and
patient samples). We will utilize these high-dimensional datasets to elucidate the molecular mechanisms by
which IFN supports the production and expansion of this cell type. These data will likely reveal novel therapeutic
approaches that can be leveraged for future therapies.

Public health relevance
PROJECT NARRATIVE We propose to study the mechanisms by which pathogenic T cells in systemic lupus erythematosus are formed and sustained.